Automation of Liquid Nitrogen Freezer for Cryopreservation of Unique Human Biospecimens

PROJECT SUMMARY/ABSTRACT
This application by the Biorepository and Tissue Technology Shared Resource (BTTSR) requests funding for a
BioStore™ M60 Cryo-190°C liquid nitrogen (LN 2) system to support ongoing collection of human solid
biospecimen and long-term storage for future research, a goal in line with those of the NCI-designated
comprehensive Moores Cancer Center (MCC), at the University of California, San Diego. This automated
BioStore M60 Cryo system is a cryogenic storage unit that offers sample storage automation, cold chain
management, and improved security and accessibility while maintaining sample protection within a liquid
nitrogen environment. The requested instrument goes beyond conventional manual LN2 Freezers with the
highest sample protection, comprehensive inventory management systems, superior user safety measures, and
LIMS connectivity. The BioStore™ M60 Cryo -190°C System provides sample integrity, security and tracking
with availability of Full 21-CFR-11 reporting capability.
Adequate preservation of biospecimens has been proven to be critical to obtain reliable and reproducible results
in genomics, transcriptomics, proteomics, developing PDX models, immunoprofiling and many other assays.
Biological assays which depend on -190°C stored biospecimens can be extremely sensitive to transient
temperature exposure thus the superior quality control measures of this system are needed. The new BioStore™
M60 Cryo -190°C system will ensure that our users have access to high quality human biospecimens, and the
automation of the system will also enhance the integrity of samples during storage and retrieval by minimizing
transient temperature exposure. The BioStore™ M60 Cryo -190°C system will be located, administered and
maintained in the existing BTTSR facility at the MCC.

Public health relevance
Project Narrative The College of American Pathologists (CAP)-accredited Biorepository at the Moores Cancer Center, UC San Diego, has developed a 5-year plan towards automated, sustainable storage robotic solutions for human biospecimens. By updating our current cryogenic storage system, we will provide storage efficiency, safe handling, GMP support, LIMS, access control, added safety, chain of condition, hence ensuring the best possible quality of biospecimens. This shared resource has the expertise, space, and institutional support necessary to expand and automate its cryopreservation equipment for ongoing collections that use -190°C freezer storage.